Association analysis of rare variants with sequencing data

DESCRIPTION (provided by applicant): An emerging research area in genetics is to detect associations between complex traits and rare variants (RVs) with next-generation sequencing data. Due to extremely low minor allele frequencies (MAFs) of RVs, many existing tests for common variants (CVs), such as the univariate test on each individual variant, most popular in genome-wide association studies (GWAS), may no longer be suitable. To boost statistical power, a common theme of existing association tests is to aggregate information across multiple RVs in a gene. With sequencing data, since the majority of RVs may not be causal, in which case most, if not all, existing association tests have severely deteriorating performance. We propose developing and evaluating an adaptive test that can maintain high power across various situations, including in the presence of opposite association directions and of many non-associated RVs. We will extend the proposed adaptive test to pathway analysis and multi-trait analysis. The developed methods will be applied to detect associations of RV-cardiovascular traits with the sequencing data from the CHARGE-S and ESP cohorts. We will develop and distribute software implementing the proposed methods.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposed research is expected not only to advance data analysis methodology and practice for DNA sequencing data, but also to contribute valuable analysis tools to the elucidation of genetic components of complex human diseases and traits. __SpecificAimsTextDelimiter__ Specific Aims An emerging research area in genetics is to detect associations between complex traits and rare variants (RVs) with next-generation sequencing data. Due to extremely low minor allele frequencies (MAFs) of RVs, many existing tests for common variants (CVs), such as the univariate test on each individual variant, most popular in genome- wide association studies (GWAS), may no longer be suitable. To boost power, a common theme of most existing association tests is to aggregate information across multiple RVs in a gene. In spite of high demand and intensive efforts, however, it is in general unknown under which situations which tests are likely to perform well. Furthermore, since the majority of RVs may not be causal, in which case most, if not all, existing tests have severely deteriorating performance (as to be shown), developing new association tests tailored to RVs is indispensable. The overarching goals of this proposal are to develop novel and powerful statistical tests for complex disease-RV association, assess these new and existing association tests to provide the geneticist some practical guidelines on their use, and apply them to real resequencing data for new discovery. Aim 1. Powerful and versatile gene-centric testing on multiple RVs. Since it has been observed that the vast majority of RVs do not appear to confer risk while existing tests have deteriorating performance with many non-associated RVs among the group of the RVs to be aggregated, it is important to develop a highly adaptive test that can maintain high power across various situations. We pro- pose such a test, called an adaptive sum of powered score (aSPU) test, a generalization of some existing pooled/collapsed/burden association tests. The method can also rank the RVs by their likelihoods of being causal, thus facilitating the selection or prioritization of causal RVs. The proposed aSPU test is developed under a gen- eral regression framework, thus can accommodate various types of quantitative, binary and survival phenotypes and can adjust for covariates. We will extend the method to robust analysis of quantitative traits and powerful joint testing of both RVs and CVs. We will also consider the issue of population stratification (PS), both a new opportunity and a new challenge offered by sequencing data, such as whether only a subset or all of CVs or RVs or their combination should be used to best adjust for PS in a fine scale. We will compare the performance of the proposed aSPU test with existing tests. Aim 2. Powerful and versatile pathway-based testing. Since genes participate in biological processes coordinately as in pathways or gene sets, it is hypothesized that multiple RVs of a subset of the genes in a pathway may be causal to the same complex disease. To boost statistical power, we propose extending our adaptive and versatile tests to pathway analysis. We will evaluate and compare its performance with existing pathway-based or gene-set methods, most of which were developed for CVs or gene expression data and may not be suitable for RVs. Aim3. Powerful and versatile multiple trait-multiple RV association testing. Since multiple relevant traits, e.g. complex disease and comorbidity conditions, may share some common susceptibility loci, association testing on multiple traits should be developed and applied to improve statistical power and detect pleiotropic genetic effects. We extend our adaptive and versatile association tests to the generalized estimating equation (GEE) framework for regression analysis of multiple correlated traits and multiple RVs; it can also handle multiple types of traits and other covariates. We show that our proposed method can be more powerful than the commonly used single trait-based and several existing multiple trait-based tests in the presence of pleiotropy. Aim 4. Applications to resequencing studies. We will evaluate and apply the proposed tests (and many existing tests) to detect associations of RVs with cardiovascular traits with data generated from the CHARGE-S, a large-scale sequencing project, including whole- exome sequencing of 6,000 individuals, whole-genome sequencing of 1,500 individuals, and ExomeChips of 15,000 individuals from the deeply phenotyped NHLBI ARIC cohort. We will validate/replicate our findings us- ing the Exome Sequencing Project (ESP) data (whole exomes of 6,800 individuals). Aim 5. Software development. We propose developing public-domain software implementing the proposed methods in R, a free statistical computing environment.The software as R packages together with well-written documentation will be posted on CRAN and other public web sites to facilitate data analyses in the wider community.